Dual reinforcement contingency management for alcohol use disorders

Abstract
In an ongoing project, we are finding that a contingency management (CM) intervention reinforcing
attendance at outpatient substance abuse treatment decreases objective indices of drinking. Benefits of CM
are noted during the intervention period and long term, even after the reinforcement for attending treatment
ends. These preliminary results reinforcing attendance are excellent, and we hope to replicate and extend the
beneficial impact of the CM intervention in the proposed study.
In our ongoing study, we are using transdermal alcohol technology to assess drinking. This technology
accurately assesses alcohol use in the natural environment, but it is bulky to wear and expensive, limiting its
use in clinical settings. In this project, we will evaluate the use of another objective indicator of drinking.
Phosphatidylethanol (PEth) is a direct biomarker of alcohol that can detect moderate to heavy drinking with
high sensitivity and specificity over 3-week periods. Reinforcing negative PEth results alongside attendance
may increase the proportion of patients who respond to CM during and post treatment. In the proposed study,
we will collect PEth samples every 3 weeks for 12 weeks in 150 patients initiating outpatient treatment for
alcohol use disorders. Using a two-group randomized design, patients will be assigned to standard care with
PEth monitoring alone or with CM for attending treatment and submitting PEth negative samples. Compared to
standard care and monitoring, we expect that the CM intervention will result in greater attendance, more PEth
negative samples, and higher proportions of self-reported non-drinking days, along with lower proportions of
heavy drinking days, over the short term and the long term, measured throughout a 12-month follow-up. We
anticipate that the reinforcement intervention will decrease other drug use and sexual risk behaviors that
spread HIV, reduce psychiatric symptoms, and improve quality of life as well. We will also evaluate the cost-
effectiveness of this intervention. Although it adds costs, CM may be cost-effective in improving outcomes and
reducing personal and societal harms associated with alcohol use disorders, and reinforcing attendance may
enhance clinic reimbursement rates. Results from this study will be important for paving the way toward
integrating CM in the treatment of alcohol use disorders and for using this biomarker of alcohol use in clinical
trials and practice settings more generally. PEth, with a 3-week time frame, may be an ideal method to monitor
outcomes in many populations of drinkers and to reinforce the absence of hazardous drinking once patients
engage in care and achieve initial periods of abstinence or greatly reduced drinking.